Determining the relationship between NAAG and memory deficits in schizophrenia in mid- to late- life

Project Summary
Cognitive deficits are a core feature of schizophrenia and are particularly prominent in patients of advanced
age. In fact, schizophrenia patients are likely to experience worsening cognitive symptoms in mid- to late-life.
There is an abundance of evidence suggesting that targeting glutamate-mediated neurotransmission could
modulate neural connections that are responsible for the abnormal signaling and improve memory symptoms
of schizophrenia. GRM3, the gene that encodes the metabotropic glutamate receptor 3 (mGlur3), is a GWA-
associated risk gene for schizophrenia, and alterations in mGluR3 signaling change memory performance in
both animal models and humans. N-acetyl-aspartyl-glutamate (NAAG) is a peptide neurotransmitter that acts
as the only selective endogenous agonist of mGluR3. The amount of NAAG in the synapse is primarily
regulated by glutamate carboxypeptidase II (GCPII), which inactivates NAAG by cleaving the glutamate from
NAA. Increasing NAAG levels, through the inhibition of GCPII, may be effective for the treatment of memory
dysfunction in schizophrenia, as suggested by several animal models. This could be particularly relevant in
patients with schizophrenia in mid- to late-life, as GCPII levels are known to rise in the brain with aging.
However, there is a paucity of human data regarding the functional role of NAAG in cognition, and the
behavioral and neural consequences of human NAAG modulation is currently unknown. Before investing in the
development of a GCPII inhibitor, it is critical to determine the relationship between NAAG levels, memory
performance, and neural activity during memory in mid- to late-life. We propose to measure NAAG levels using
magnetic resonance spectroscopy in schizophrenia patients and healthy adults in mid- to late-life and to
correlate these NAAG levels with declarative and working memory performance (Aim 1) and neural activity
during memory tasks measured by functional MRI (Aim 2) in the same individuals. We expect to 1) identify
memory domains that are associated with differential NAAG levels, 2) identify memory task-related brain
activity patterns that are regulated by NAAG, 3) determine if the relationship between NAAG and memory if
changes from 35y to 65y, and 4) determine if the influence of NAAG on memory and brain function is greater in
patients with schizophrenia in mid- to late-life compared to healthy adults. This proposal will therefore link
variation in human NAAG levels with memory performance and brain function that would shed light onto the
pathophysiology of memory dysfunction in schizophrenia in mid- to late-life and guide future development of
treatments aimed at modulation of NAAG levels to improve memory symptoms. Furthermore, these findings
will inform the future use of neuroimaging biomarkers in relevant clinical trials involving modulation of NAAG
and mGluR3 for the treatment of memory dysfunction in mid- to late-life.

Public health relevance
Project Narrative The proposed study will determine the link between N-acetyl-aspartyl-glutamate (NAAG) levels in the brain, memory performance, and memory task-related brain activity in patients with schizophrenia and healthy adults in mid- to late-life. Doing so will provide important insights for development of treatments aimed at modulation of NAAG levels to improve memory deficits in patients with schizophrenia and related memory disorders in mid- to late-life, as well as identify neuroimaging biomarkers for future relevant clinical trials.